Cerebrospinal fluid (CSF) and peripheral markers of the neuropsychiatric sequelae of COVID-19: The Generation C-SF pregnancy study

Summary
The placenta is an integral organ during pregnancy, being a regulator of the in-utero environment including
maternal neuroendocrine changes. Previous efforts have begun to elucidate a connection between HPA-axis
gene expression in the placenta and maternal mental health, implicating that dysregulation of gene expression
in the placenta has potential consequences for both the physical and mental health of the pregnant individual.
Fully interrogating this connection is imperative, and there is an urgent need to expand our understanding of
the role placental gene expression plays. This is especially important in the context of the coronavirus disease
2019 (covid-19) pandemic, as infections and the inflammatory responses they elicit have the potential to have
a negative effect on maternal mental health. The parent study (Generation-CSF) is currently using a large
ongoing pregnancy cohort to investigate the impact of SARS-CoV-2 infection and subsequent inflammatory
changes on maternal mental health and cognition through paired blood and CSF (Cerebrospinal fluid) samples
and psychiatric and cognitive assessments during and after pregnancy. This supplement aims to expand upon
this investigation by clarifying the role that the placenta, as a regulator of neuroendocrine chances, could be
playing in this relationship. By utilizing already collected placental samples and existing RNAseq data to
investigate immune and inflammation genes in the placenta, which have yet to be explored in connection to
maternal mental health, this supplement provides important additional information about what could be driving
the proposed negative system wide changes that occur after infection during pregnancy. We hypothesize that
SARS-CoV-2 infection during pregnancy will be positively associated with the expression of immune and
inflammation markers in the placenta and maternal blood and that this upregulation will serve as a driver for
increased EPDS scores at birth and at 6 weeks postpartum. In Aim 1 we will examine the association between
SARS-CoV-2 infection and the expression of a curated list of 497 immune and inflammation related genes in
the placenta with EPDS scores at birth and 6 weeks postpartum. In Aim 2 we will examine the association
between cytokine levels in the blood (Il-1b, Il-17A, Il-6, CRP) and placental genes linked to SARS-CoV-2 and
postpartum depression (EPDS scores) at birth and at 6 weeks postpartum. Finally, in Aim 3 we will validate key
findings/candidate genes from Aim 1 and 2 in placental samples using quantitative gene expression profiling
(qPCR).

Public health relevance
The proposed study will investigate the inter-relationship of SARS-CoV-2 infection, placental transcriptome, cytokine levels in maternal blood, and postpartum depression. This project aims to identify key genes in the placenta that could be serving as a driver for postpartum depression after SARS-CoV-2 infection and aims to elucidate the role that cytokine dysregulation in the maternal blood, at a system wide level, could be playing in this process. The results will enhance our understanding of the tie between placental functioning and maternal mental health.